ALL immunobiology and the bone marrow niche

This year we reported CD22-targeted CAR T cells induce remission in B-ALL that is naive or resistant to CD19-targeted CAR immunotherapy. Chimeric antigen receptor (CAR) T cells targeting CD19 mediate potent effects in relapsed and/or refractory pre-B cell acute lymphoblastic leukemia (B-ALL), but antigen loss is a frequent cause of resistance to CD19-targeted immunotherapy. CD22 is also expressed in most cases of B-ALL and is usually retained following CD19 loss. We report results from a phase 1 trial testing a new CD22-CAR in 21 children and adults, including 17 who were previously treated with CD19-directed immunotherapy. Our results also highlight the critical role played by antigen density in regulating CAR function. In addition, with Peter Aplan, we showed myeloablative hematopoietic stem cell transplantation improves survival but is not curative in a pre-clinical model of myelodysplastic syndrome. The work on this project concluded in February 2018.